Towards Suppression and Elimination of HIV in the CNS

PROJECT SUMMARY/ ABSTRACT
Despite the success of combined antiretroviral therapy (cART) to diminish peripheral infection,
HIV-1 can establish an infection in the central nervous system (CNS), resulting in the development
of cognitive, behavioral, and motor deficits associated with HIV-1 associated neurocognitive
disorders (HAND). Once infected, the CNS acts as a viral reservoir that is difficult to treat and
eradicate. Mononuclear phagocytes (MP, e.g., perivascular macrophages and microglia) are
important reservoirs in the immune-privileged CNS. The proposed studies are designed to
address the unique dynamics of HIV infection in CNS and explore novel therapeutic strategies
that target MP, ensure viable delivery across the blood-brain barrier (BBB) to eliminate the HIV
reservoir and reduce inflammation. HIV-induced activation and viral replication in MP are relevant
targets that that are the focus of our ongoing novel approaches through multiple pharmacological
agents. These approaches include design and development of: 1) MP-specific ribonucleoside
chain terminators (rNCTs) and their phosphate prodrugs, and 2) NADPH oxidase (NOX) inhibitors
that cross the BBB and target MP, and 3) JAK inhibitors that block/interrupt the activation state of
MP and can reduce inflammation. Selected therapeutic agents will be analyzed for their in vitro
antiviral potency, and to assess biochemistry, toxicology, and cellular pharmacology parameters.
We have recently identified low or sub-nanomolar MP-specific HIV inhibitors with a high
therapeutic index. These will be evaluated in vivo to assess CNS pharmacology and response
(including behavior and pathology) to treatment using two distinct retrovirus CNS animal models
we have previously established including SCID mouse model intracranially injected with HIV-1
infected MP, and macaque model infected with SIVmac239. Results from these studies will
identify new adjunctive therapeutic strategies which together with current cART should provide
improved targeted therapy to MP. The ultimate goal is to suppress virus and eliminate these HIV-
1 reservoirs in the CNS that should lead to improved treatments to reduce risk(s) of developing
HAND.

Public health relevance
PROJECT NARRATIVE Chronic infection and inflammation results in the development of HIV-1 associated neurocognitive disorders (HAND) in a substantial number of people living with HIV (PLHIV). In the era of combined antiretroviral therapy (cART), it is apparent that eradication of HIV-1 cannot occur without elimination of viral reservoirs, including the central nervous system (CNS). Our approach is to investigate new adjunctive therapeutic strategies from three distinct classes of compounds to target improved therapy targeting myeloid cells as viral reservoirs in the CNS (i.e., microglia, MP) and eliminate these reservoirs and/or reduce risk of developing HAND.